Realistic Numerical Models of Brain Electrical Currents

[unreadable] DESCRIPTION (provided by applicant): Functional imaging techniques are important to brain researchers and clinicians alike because many phenomena cannot be observed by anatomical techniques alone. Among functional imaging methods, only magneto- and electro-encephalography (MEG, EEG, or jointly M/EEG) can noninvasively resolve events with a millisecond time scale. The aim of this work is the development, validation, and commercialization of a detailed, realistic model of electrical current flow in the head, the currents originating from sources within the brain, and measured electrically and/or magnetically on or near the surface of the scalp. 3D finite element models of individual heads will be constructed with the aid of magnetic resonance imaging (MRI). The finite element method provides the needed flexibility for modeling an asymmetric, anisotropic, and inhomogeneous medium like the head. These subject-specific models may be used as the basis for high-resolution methods for estimating neural activity source location and time course. [unreadable] [unreadable] The algorithms will be incorporated into prototype software, and the software validated with both simulated and experimental data. The software will comprise a realistic modeling module of our EMSE suite, our PC/Windows-based program suite for analysis and display. The algorithms and resulting software may be used to study both normal brain function, such as measurements in cognitive neuroscience which may be studied with evoked response/event related potentials or spontaneous EEG, and in diseases of the brain, such as the epilepsies, where precise spatial and temporal resolution may be of value for diagnosis and presurgical evaluation.